Use of C. elegans as a model to study aging-associated neurodegeneration

Aging can cause neurodegeneration and is also a major risk factor for neurodegenerative diseases.
However, the molecular mechanisms underlying aging-­associated neurodegeneration are not well understood
yet. Therefore, our-­long-­term goal is to understand the molecular mechanisms undying neurodegeneration in
aging and neurodegenerative diseases. The objective of this proposal is to use C. elegans as a model to
uncover novel mechanisms underlying aging-­associated neurodegeneration. This proposal builds on our
recent punished work, in which we revealed that antimicrobial peptide (AMPs) released by epidermal cells in
aged animals lead to neurodegeneration through activating a neuropeptide receptor (NPR). Importantly, our
collaborators showed that signaling via the same molecular players (AMPs and NPR) also leads to neurite
degeneration in rat cortical neurons, supporting the conclusion that the mechanisms identified in our system
are preserved in mammalian neurons. Based on these exciting findings, we propose to use genetic and
genomic methods to further examine the signals that cause the overexpression of AMPs in aged animals and
to uncover the transcriptional regulators that lead to neurodegeneration upon aging. We believe that careful
analysis of aging-­associated neurodegeneration in C. elegans will reveal previously unknown but potentially
conserved mechanisms that govern fundamental features of neurodegeneration in aging. This proposal will
determine the function and regulation of AMPs in aging-­associated neurodegeneration (Aim 1), and establish
cell-­autonomous mechanisms underlying neurodegeneration in aged animals (Aim 2). It is expected that
completion of this proposal will lead to the discovery of novel mechanisms of aging-­associated
neurodegeneration, the establishment of C. elegans PVD neurons as a powerful model to study aging-­
associated neurodegeneration, and the generation of new tools for further studies. As many neurodegenerative
disorders are associated with aging, our studies may lead to a better understanding of the pathogenesis of
these diseases.

Public health relevance
Aging is a universal phenomenon, and aging in humans dramatically increases the probability of developing neurodegenerative diseases. In this proposal, we take advantage of the model organism Caenorhabditis elegans to investigate molecular mechanisms underlying aging- associated neurodegeneration. Completion of our studies will pave the way to fully understand aging- associated neurodegeneration and likely provide new drug targets for potential clinical studies of neurodegenerative disorders.